Career Enhancement

ABSTRACT
NEPTUNE provides a unique opportunity for training scientists dedicated to studying human glomerular disease.
Historically, few researchers have been drawn to this rare disease area of study, and as a result, few established
investigators have emerged to conduct glomerular disease research. Even fewer investigators can employ new
experimental approaches that would allow the use of Precision Medicine in this realm. NEPTUNE has
transformed this environment by assembling a talented community of scientists with diverse backgrounds, by
collecting unique resources, and by uncovering outstanding research opportunities that can be exploited to
expand the pool of scientists to utilize modern experimental approaches in advancing understanding and
treatment of glomerular disease. NEPTUNE will continue to exploit its maturing environment through provision
of the already successful Career Enhancement Program. As part of this program, NEPTUNE will fund career
development fellowships designed to support advanced post-doctoral and junior faculty, or established
investigators interested in redirecting their investigative focus, who are preparing to become independent
investigators in clinical and translational research in human glomerular disease. In addition, NEPTUNE will
expand activities in the Career Enhancement Program by providing a network-wide training and mentoring
program offered to all interested trainees and junior faculty, in an effort to expand the group of individuals who
are served by NEPTUNE resources—including those who are selected for NEPTUNE Career Development
Grants as well as others in early career stage.